Brain Structural Biomarkers of Risk and Resilience to Pain Chronification

PROJECT SUMMARY
Chronic pain is highly prevalent and costly to individuals and society. Once chronic, pain is very hard to treat
or reverse making early identification key for prevention and early treatment to improve long-term outcomes.
Recent brain imaging data from our lab as well as others have provided evidence that the structural properties
of the limbic brain, such as the volume and/or shape of nucleus accumbens (NAc), amygdala, and hippocampus
can predict the likelihood of “chronification” of low-back pain after an episode of sub-acute low back pain (SBP)
(duration 6-12 weeks). The role of the limbic brain in predicting vulnerability or resilience to chronic pain fits with
the general understanding that chronic pain is partly due to an interaction between peripheral nociceptive input
and vulnerable limbic brain circuitries, which are known to mediate the negative affective and aversive learning
associated with chronic pain. Hence, understanding how the structural properties of the limbic brain circuitries
predict risk or resilience to chronic pain in humans is innovative and has high translational significance.
However, the brain imaging studies of the transition to chronic pain remain very limited in number and
scope and, hence, we still have a poor understanding of the exact limbic circuitry and structural connectivity
underlying risk of or resilience to chronic pain. To date, only one small study reported that local white matter
properties can predict resilience to pain chronification. Furthermore, no brain imaging study of pain chronification
investigated the role of important biological variables like sex or established clinical phenotypes like the presence
or absence of a neuropathic component of the low back pain. Therefore, the overarching aim of this proposal is
to use state of the art structural mapping techniques to study local anatomical properties (e.g. volume, shape,
neurite orientation) and white matter connectivity to identify biomarkers for pain chronification. We will use 2
different approaches, one based on biologically plausible hypotheses, and one based on data driven hypotheses
identified in our preliminary data. In addition, the proposal will explore the effect of sex and clinical low-back
pain phenotypes on theses biomarkers. We will recruit SBP patients and obtain brain anatomical and multi-shell
diffusion weighted imaging data at baseline and at 6 months follow-up. Patients will be classified as recovered
or persistent after the follow-up visit. Aim 1 will test baseline local and global gray, white matter differences
between recovered and persistent patients in areas of the limbic brains like NAc, amygdala, hippocampus,
anterior cingulate cortex, and white matter pathways known for their role in chronic pain (e.g., the cingulum
bundle and internal capsule) and assess whether these measures change at follow-up. Aim 2 will use a data-
driven approach to examine global and local gray, white matter properties predicting risk or resilience to chronic
pain. Finally, aim 3 will explore the effect of sex and presence or absence of radiculopathy symptoms on the
biomarkers identified in Aims 1 and 2.

Public health relevance
PROJECT NARRATIVE Chronic pain has a staggering economic cost and causes huge suffering to individuals. Once pain is chronic it is very hard to reverse and, hence, the best strategy to prevent chronic pain is early identification and treatment of high-risk individuals. This application aims to identify structural gray and white matter biomarkers of risk and resilience to pain chronification after the onset of low-back pain by testing specific hypotheses based on existing knowledge of chronic pain and the brain while at the same time addressing the influence of sex and types of clinical presentations (i.e., presence or absence of sciatica).